Substance Use Modeling Consortium Workshop to Support the Public Health Response to the Overdose Crisis in North America

PROJECT SUMMARY
Drug overdose resulted in 106,699 deaths in the U.S. in 2021, an age- adjusted rate of 32.4 per 100,000
population, a 14% increase over 2020, and the highest rate ever recorded.1 Beyond overdose, injection opioid
and methamphetamine use are driving up rates of HIV infection, hepatitis C virus (HCV) infection, and
endovascular and soft tissue bacterial infections.2 The overdose crisis has also affected Canada and Mexico,
leading to a call for a North American approach to addressing the overdose crisis. Simulation models provide a
structured environment for decision makers to compare the predicted effects of proposed policy alternatives
over an extended time horizon on population-level outcomes such as overdose, HIV, and HCV. Several public
agencies are currently funding overdose simulation modeling efforts in North America, including NIDA, CDC,
FDA, the Canadian Institutes of Health Research (CIHR), and Canadian provincial agencies.
Our goal is to improve the speed, validity, effective knowledge translation, and

Public health relevance
PROJECT NARRATIVE Injection opioid and stimulant use are driving up rates of overdose, HIV, HCV, and bacterial infections in the U.S., Canada, and Mexico. We propose to assemble leaders in simulation modeling of drug use, HCV, and HIV in North America, people with lived and living experience (PWLLE) using drugs, and people influencing drug policy to continue to hold the annual Substance Use Disorder (SUD) modeling workshop. The meeting will leverage currently funded modeling efforts through the NIH and other agencies to generate opportunity to swiftly develop and share best practices, forge meaningful collaborations between researchers and PWLLE, and maximize public health and policy impact.